MAPPING OF THE REGULATORY GENES AND ELEMENTS OF HUMAN RETROVIRUSES

This project involves the molecular cloning, characterization, and functional mapping of the regulatory elements and regulatory genes (e.g., tat) of human immunodeficiency virus -1 and -2 (HIV- 1 and HIV-2). We have recently shown that several isolates of HIV-2, as well as simian immunodeficiency virus (SIV), possess a function tat gene, irrespective of their pathogenic potential in the natural host. Possibly relevant to virus latency, HIV-1 and HIV-2 gene expression can be stimulated by immune activation and heterologous transactivators such as human T-lymphotropic virus- 1 (HTLV-I) and oncogenic DNA viruses. DNA sequencing and functional mapping of the long terminal repeats (LTR), 3'orf and tat genes have revealed that the regulatory elements and genes of HIV-2 are related to HIV-1 and that various isolates of HIV-2, as well as SIV are more related among themselves than to HIV-1.